Laboratory capacity FDA CVM Vet-LIRN veterinary diagnostic laboratory program

Title: Laboratory Capacity FDA CVM Vet-LIRN Veterinary Diagnostic Laboratory Program
Project Summary/Abstract
Veterinary diagnostic laboratories (VDLs) are pivotal not only in preventing and controlling animal
diseases but also in monitoring zoonotic agents. Additionally, they play a vital role in detecting
contamination in feed from microbiological or chemical agents. VDLs collaborate with public health
laboratories, food diagnostic laboratories, and other agencies in monitoring trends in antimicrobial
resistance among bacteria isolated from animals. The early and accurate detection of zoonotic and
foodborne pathogens, along with the analysis of antimicrobial resistance, constitutes a top priority for the
Center of Veterinary Medicine-FDA. The primary objective of this application is to secure funding
through a cooperative agreement to procure equipment, supplies, training, and proficiency testing
required by the FDA Vet-LIRN annually over at least five years. While the Clinical Diagnostic
Laboratory (CDL) at the College of Veterinary Medicine, Ohio State University, will benefit from this
agreement, the FDA CVM Vet-LRN Veterinary Diagnostic Laboratory Program will continue building
national laboratory capacity. The specific aims of this cooperative agreement include: 1) strengthening
coordination with veterinary diagnostic laboratories through the Vet-LIRN Program, participating in three
key project areas (sample analysis, providing data, additional projects/method validation), 2) training,
equipping, and proficiency evaluating technicians to conduct necessary testing for ensuring food supply
safety and accurate diagnosis of pathogens in clinical samples, and 3) participating in the Vet LIRN
Whole Genome Sequencing Project by supplying bacterial isolates as a Source Laboratory.

Public health relevance
Project Narrative Veterinary diagnostic laboratories (VDLs) play a pivotal role in maintaining animal health, aiding veterinarians, animal owners, researchers, and those involved in the veterinary sector. These laboratories are also integral to the public health sector's efforts in monitoring and preventing zoonotic diseases. There is a crucial need to build and maintain the capability of VDLs. Collaborative efforts among VDLs should also be coordinated to maximize the use of resources. This project seeks funding to enhance and sustain the Clinical Diagnostic Laboratory (CDL) at The Ohio State University's Veterinary Medical Center. The CDL will actively engage in the CVM FDA Vet-LIRN program, focusing on three key areas: 1) contributing bacterial samples for the Vet-LIRN Whole Genome Sequencing Project, 2) upgrading laboratory equipment, and 3) facilitating staff development through training and participation in proficiency tests.